Predicting neonatal health outcomes from placental and fetal brain extracellular vesicles in pregnant opioid users

Project Summary
We are submitting this proposal in response to RFA-HD-23-032 (HEAL initiative: Opioid Exposure and Effects
on Placenta Function, Brain Development, and Neurodevelopmental Outcomes).
The rate of newborns with neonatal opioid withdrawal syndrome (NOWS) increased dramatically over the past
decade. NOWS has long-term health consequences including poor growth, seizures, and altered
neurodevelopmental and cognitive function. However, not all neonates exposed to opioids during gestation
develop NOWS or require treatment. It is impossible to predict which infants will experience NOWS and require
pharmacotherapy. Maternal opioid dose is not a predictor for NOWS, and though genetics and co-exposure to
other drugs have been associated with NOWS severity, no factors have been identified that predict NOWS risk.
Further, the mechanisms by which some infants develop NOWS while others do not are not understood.
Accessible biomarkers of changes induced by opioid use for the placental and fetal brain would be highly
valuable for deciding which infants will need opioid therapy for NOWS and making personalized risk
assessments for opioid exposed infants. They could also shed light on the biological pathways that lead to the
worst effects of opioid exposure during gestation.
Extracellular vesicles (EVs) derived from the Placenta (PEV) or Fetal brain and central Nervous system (FNEV)
can cross the fetal/placental barrier and can be isolated from maternal blood. They represent a powerful
accessible tool to provide insight on placental health and fetal neurodevelopment and damage. This project will
characterize PEVs and FNEVs profiles in healthy pregnancies and from pregnancies complicated by opioid use
disorder, stratified by need for NOWS pharmacotherapy. For PEVs, we will focus on a panel of placental stress
and serotonin processing markers, and for FNEVs we will focus on markers reported to be altered in the brains
following opioid exposure during gestation. Our studies will lead to assays that define NOWS risk pre-birth and
will bring new insights into the molecular pathways impacted by opioid use.

Public health relevance
Narrative This project proposes to study extracellular vesicles and serotonin that circulate in blood during pregnancy, which can offer a snapshot of placental and fetal health during development. Our proposed studies will utilize highly sensitive technologies to analyze these circulating nanoparticles in women with healthy pregnancies and in women using opioid drugs. This study will allow us to develop a better understanding and new biomarkers to determine if newborns exposed to opioid drugs in utero will need treatment for neonatal opioid withdrawal syndrome.